Clinical outcomes for asynchronous teledermatology

Background: Store-and-forward teledermatology is a significant part of Department of Veterans Affairs’
telehealth portfolio. While considerable evidence supports teledermatology’s potential to provide timely access
to expert dermatologic care, its effectiveness in achieving clinical outcomes that are equivalent to usual in-
person care has not been as well documented due to the lack of objective outcome measures for many skin
diseases. Clinicians typically document skin diseases using non-standardized qualitative language. Manual
review to extract meaningful outcomes data from relatively unstructured text is typically prohibitive.
Significance/Impact: Natural language processing (NLP) offers a previously unexplored approach to
objectively and systematically identify relevant text in the electronic medical record to gauge patients’ clinical
responses following either in-person dermatology and asynchronous teledermatology consultation. This
project will leverage NLP to follow clinical courses of important skin conditions in the medical record and to
compare the outcomes and effectiveness of teledermatology relative to usual office-based dermatology
consultation. It will also serve as a test for other outcome measures such as access times that are often
assumed to be proxies for quality of care for Veterans. The results may help influence VA telehealth strategy
and policies to enhance access of patients to high quality skin care and to improve patient safety.
Innovation: This project represents a novel application of NLP methods to understand how key clinicians
document skin conditions and to provide a large-scale, systematic and rigorous assessment of
teledermatology’s effectiveness in caring for Veterans with a variety of skin diseases. The project will also
result in NLP systems which may be translatable to create practical operational quality management tools for
monitoring the quality of follow-up care of both dermatology and teledermatology patients in VA.
Specific Aims: Aim 1 will survey expert and non-expert clinicians to learn how each group evaluates and
documents clinical change in five common skin diagnostic categories. We will test novel annotation methods,
and identify differences between clinician groups in annotated survey responses. Aim 2 will use our annotated
data sets to train and validate NLP models to extract concepts and relationships for our five diagnostic
categories from actual VA clinical notes. This information will be used to create a document classifier capable
of assigning a clinical change status to follow-up notes. Aim 3 will integrate output from our NLP tools to
assign an overall clinical outcome to dermatology and teledermatology referrals. Other important clinical
events and activities available as structured data will be correlated with NLP outcomes to further interpret their
significance. Commonly used access outcome measures will also be compared as a test of their validity.
Methodology: Aim 1 will survey dermatologists and primary care providers to annotate and compare their
responses. Aims 2 and 3 will create trained and validated NLP tools to assign condition and outcome status to
actual clinical notes. Aim 3 will use our tools to compare clinical outcomes following teledermatology and
dermatology consultation and will will utilize the VA Corporate Data Warehouse to obtain structured data on
other key clinical events and access measures.
Implementation/Next Steps: The NLP models that result from this project may be extendable beyond routine
in-person and teledermatology care to generally track clinical course outcomes related to other forms of
telehealth such as dermatology e-consults and video telehealth. In addition, the models may be adaptable to
create a practical dashboard tool to allow providers and quality management staff to monitor the effectiveness
and quality of teledermatology delivered to Veteran patients.

Public health relevance
Asynchronous or store-and-forward teledermatology is an important pathway for increasing Veterans’ access to expert skin care. It is not clear, however, that access consistently translates into clinical outcomes that are comparable to usual in-person care. This project uses a form of artificial intelligence known as natural language processing (NLP) to learn how key clinicians document skin disease, and to analyze patients’ medical records to compare outcomes for five common but significant skin diseases that have been managed by either teledermatology or by usual in-person care. The results will be the first systematic application of NLP to assess telehealth outcomes, may identify areas to remedy and to strengthen VA’s teledermatology and telehealth programs, and may suggest enterprise-wide approaches to enable clinicians and staff to monitor and improve teledermatology and dermatology outcomes in Veteran patients.